Elucidating spatio-temporal innate immune cell modulation of Mycobacterium tuberculosis stress response and replication heterogeneity

PROJECT SUMMARY/ABSTRACT
Heterogeneity, including in Mycobacterium tuberculosis (Mtb) replication status and local environment, is a
hallmark of Mtb infection and strongly impacts infection outcome and disease treatment. Spatial organization of
Mtb lesions in the lung affect environmental signals that the bacteria receive, with consequent effects on Mtb
stress responses and growth. For example, Mtb within the necrotic lesion core are extracellular, while Mtb in the
lesion cuff reside within immune cells, resulting in exposure to different oxygen levels, pH and nitric oxide (NO)
stress, among other signals. Mtb also exhibits shifts in metabolism over the course of infection, with lipid
metabolism vital as infection progresses and lipid-rich foamy macrophages form. Importantly, environmental
non-uniformity exists even within each lesion sublocation, likely driven by proximity to/residence in different
immune cell types and their specialized antimicrobial programming. Consistent with this hypothesis, we observe
a greater dependence on interstitial macrophages (IMs) in controlling Mtb growth in necrotic lesions versus
alveolar macrophages (AMs). Different antimicrobial effectors in AMs and IMs may contribute to this difference
in controlling Mtb growth. Notably, we observe an increase in extracellular lipid levels in the periphery of the
necrotic lesion core upon macrophage depletion, corresponding with local expansion of the Mtb population. The
neutral environment of the lesion core versus the slightly acidic macrophage phagosome compartment may
represent a mechanism fueling this Mtb growth. Elucidating how macrophage subtypes act to restrict Mtb growth
within lesions, and how Mtb stress responses and adaptation relates to macrophage subtypes in situ, at the
single bacterium level, is thus critical for understanding Mtb infection biology. Using the C3HeB/FeJ murine
infection model that recapitulates canonical human Mtb lesions, I will elucidate how AM/IM distribution in these
lesions over time relate to changes in Mtb exposure to NO/hypoxia, acidic pH stress, and lipid utilization, which
all have been shown to affect Mtb growth in vitro. To further probe the role of macrophages in containing Mtb
growth within necrotic lesions, macrophage depletion will be performed after lesions have formed, with tests of
inducible knockdown Mtb mutants in key lipid/pH regulators to provide mechanistic insight into how disruption of
these pathways can alter the ability of Mtb to adapt for survival and growth in necrotic lesions. This proposal
uses quantitative in situ mRNA transcript visualization techniques to assess how immune cells spatiotemporally
drive key aspects of the local environment that impact Mtb growth in necrotic lesions, knowledge vital to the
development of more effective anti-tubercular therapeutic regimens. Completion of the proposed studies will
provide the necessary training in host-pathogen interactions to enable me to transition to starting my own
independent laboratory at a research-intensive institution.

Public health relevance
PROJECT NARRATIVE Heterogeneity in multiple facets of Mycobacterium tuberculosis (Mtb), including in bacterial physiological status, is a major driver complicating disease treatment and infection outcome. Immune cells with their specialized arsenal of antimicrobial factors and different metabolic status play an important role in the local environment experienced by Mtb, leading to different bacterial responses and active versus non-active populations of Mtb within lung lesions. This project aims to provide vital spatiotemporal insight into Mtb stress response and replication in vivo, and reveal how macrophage subtypes differentially control Mtb growth in the context of necrotic lesions.